NJ ACTS: A Platform for Translational Science in New Jersey: CTSA K12 Program at Rutgers, Biomedical Health Sciences

Project Summary/Abstract
The objective of the New Jersey Alliance for Clinical and Translational Science (NJ ACTS) Institutional Career
Development Award (K12), Doctors as Valued Learning Partners (DEVELOP), is to train clinicians and
scientists with doctoral degrees to become independent investigators pursuing cutting-edge clinical and
translational sciences (CTS) research. Serving the diverse needs of early career investigators from a variety of
backgrounds (including PhD, MD, DDS, DMD, DO and PharmD), the DEVELOP program will provide a tailored
approach for each Scholar that fosters development of the key skills required of translational scientists. In
our first 4 years and despite a pandemic, the KL2 program was highly successful and its Scholars highly
productive. In response to the PAR, we now have re-imagined the KL2 program as the K12 DEVELOP program.
The DEVELOP program is comprised of intensive research experiences, a core curriculum, elective courses,
professional development training, and multi-disciplinary mentoring. The result will be a cadre of translational
Scholars with a strong understanding of mechanistic approaches to study disease processes and healthcare
delivery, the tools and methodologies used to translate important basic science discoveries to clinical and
community settings, and an understanding of how public policy should inform basic science research. NJ ACTS,
an Alliance consisting of Rutgers University, Princeton University, New Jersey Institute of Technology, and
RWJBarnabas Health system, provides an environment with substantial research resources and experienced
faculty mentors, who have a strong track record of and commitment to fostering career development of future
clinical and translational scientists. DEVELOP Scholars will be early career faculty from Alliance partners or
f a c u l t y b e i n g recruited externally. Selection of DEVELOP Scholars will be based on qualifications and
interests as well as research potential and commitment to developing a career in the translational sciences.
DEVELOP Scholars will engage in two years of individualized and intensive research under the direction of highly
qualified and productive mentors who are members of the Academy of Mentors. The mentoring program is
structured to provide the Scholar with a strong, broad, and fundamental knowledge base individually tailored
for translational science. Scholars will additionally participate in an innovative didactic curriculum consisting of
research seminars, journal clubs, and formal courses, including in the ethical conduct of research and rigor and
responsibility. Individual development plans, well-defined milestones, and regular meetings with mentors and
NJ ACTS leadership will ensure the Scholars’ successful progress towards becoming independent
translational scientists. The ample resources to enrich Scholar development as faculty underscore the continued
institutional commitment to translational science. Anticipated outcomes include excellence in career
development, increased awareness of and interest in translational sciences, and in the long-term
advancement of clinical translational sciences to improve health.

Public health relevance
Narrative The NJ ACTS K12 Career Development Program, Doctors as Valued Learning Partners (DEVELOP), prepares early career faculty for independent careers in translational sciences. The program provides mentorship, personalized training, educational opportunities, salary, research, and travel support to prepare Scholars for an independent research career. Scholars will engage in research in translational science grounded in preclinical, clinical, epidemiologic, behavioral, or community-based research methods under the mentorship of teams of highly qualified, committed faculty from the four NJ ACTS partner institutions.